Functional organization of the superior temporal gyrus for speech perception

PROJECT SUMMARY
The basic mechanisms underlying comprehension of spoken language are still largely unknown. Over the past
decade, we have gained new insights to how the human brain extracts the most fundamental linguistic
elements (consonants and vowels) from a complex and highly variable acoustic signal. However, the next set
of questions await pertaining to the sequencing of those auditory elements and how they are integrated with
other features, such as, the amplitude envelope of speech. Further investigation of the cortical representation
of speech sounds can likely shed light on these fundamental questions. Previous research has implicated the
superior temporal cortex in the processing of speech sounds, but little is known about how these sounds are
linked together into the perceptual experience of words and continuous speech. The recording of neural activity
directly from the cortical surface is a promising approach to study this since it can provide both high spatial and
temporal resolution. This proposal seeks to examine the mechanisms of phonetic encoding by utilizing
neurophysiological recordings obtained during neurosurgical procedures. High-density electrode arrays and
advanced signal processing will be utilized to unravel both local and population encoding of speech sounds in
the lateral temporal cortex. The overall goal is to determine how the brain extracts linguistic elements from a
complex acoustic speech signal towards better understanding and remediating human language disorders.

Public health relevance
PROJECT NARRATIVE The aim of this research is to reveal the fundamental mechanisms that underlie comprehension of spoken language. An understanding of how speech is coded in the brain has significant implications for the development of new diagnostic and rehabilitative strategies for language disorders (e.g. aphasia, dyslexia, autism, et alia). Abnormal perception of phonemes is a central component to language disability in all of these conditions.